Fibrotic extracellular matrix: uncovering its role in breast cancer genome stability and metabolic plasticity

PROJECT ABSTRACT
The candidate, Dr. Elizabeth Moore, seeks the proposed Mentored Research Scientist Development Award
(K01) to acquire the necessary training and experience to become an independent translational clinician-
scientist focusing on tumor microenvironmental regulation of breast cancer (BC) genome stability and
therapeutic resistance. BC therapeutic resistance remains a major hindrance to successful treatment,
particularly in the aggressive triple negative (TNBC) subtype. However, it remains unclear how therapeutic
response is influenced by the physical and biological characteristics of the tumor microenvironment and which
role altered DNA damage response (DDR) mechanisms and metabolic reprogramming play this process. In
particular, it remains to be elucidated how fibrotic remodeling of the extracellular matrix (ECM), which is a
hallmark feature of a protumorigenic microenvironment, impact BC risk and drug resistance. Given these
connections, the overall objective of the proposed studies will be to identify mechanisms of matrix-mediated
BC therapeutic resistance. Aim 1 will determine the impact of fibrotic ECM on BC DNA damage response
(DDR). Aim 2 will test how fibrotic ECM regulates the DDR and metabolism of tumor cells and their reciprocal
interactions. Aim 3 will test the functional links between fibrotic ECM, DDR, and metabolism in vivo. Aims 1 and
2 will utilize translationally relevant, high fidelity 3D tissue culture systems in which features of fibrotic ECM
remodeling can be selectively adjusted. Aim 3 will leverage a humanized mouse model of mammary fibrosis
and TNBC using human BC cell lines and patient derived xenografts of TNBC. A multidisciplinary approach,
including classic molecular techniques, gene expression analyses, metabolomics and Seahorse metabolic
analyses, and advanced imaging will be applied to achieve these aims and for the candidate to acquire
additional technical skills. Dr. Moore’s mentor is a leading expert in engineering in vitro and in vivo models to
study tumor-microenvironment interactions. Co-mentors will provide expertise in the fields of genome stability
and the DDR, cellular metabolism and metabolomics, and clinical aspects of breast cancer. Faculty expertise
and interdisciplinary collaboration in oncology research is exceptionally strong at Cornell University and further
strengthened by the training environment and exceptional core facilities. The planned career development
activities, including technical research training, coursework, attendance of seminars and conferences,
experience in grant and manuscript preparation, and the refinement of teaching, mentorship, and laboratory
management skills will support Dr. Moore’s transition to independence. The incorporation of physical and life
science approaches, utilization of highly translational in vitro and in vivo platforms, and the integration of both
extracellular and intracellular regulation of BC genome stability will enable Dr. Moore to establish a niche in
oncology research. Proposed activities will generate data for a future R01 application and launch Dr. Moore’s
faculty career in advancing the field of breast cancer biology with the goal to improve patient prognosis.

Public health relevance
PROJECT NARRATIVE Fibrotic remodeling of extracellular matrix increases breast cancer risk and contributes to therapy resistance, but the underlying mechanisms remain unclear. This proposal will elucidate how interactions with fibrotic matrix regulate breast cancer DNA damage response and metabolism, key drivers of cancer progression and therapy response. Findings from these studies will enable novel treatment strategies to counter drug resistance and tailor therapeutic strategies specifically for patients with increased breast fibrosis.